Post-transcriptional mechanisms of centrosome regulation

Project Summary
Centrosome deregulation is the leading cause of heritable microcephaly, a congenital birth defect typically
associated with intellectual disabilities and developmental delay. Centrosome dysfunction is also considered a
key driver and prognostic marker of cancer. Yet, mechanisms underlying centrosome regulation remain
incompletely understood. Centrosomes undergo cell cycle-dependent changes in composition and organization
to modulate their activity as microtubule-organizing centers, and these oscillations contribute to the diversity of
centrosome functions. One dynamic constituent of centrosomes is mRNA, yet the functional role of mRNA
localized to centrosomes remains poorly understood. In this proposal, we examine whether mRNA contributes
to centrosome regulation and functions. In Aim 1, we define mechanisms of mRNA localization to
centrosomes. In Aim 2, we uncover the regulatory contributions of two conserved RNA-binding proteins. Aim 3
examines the function of mRNA localized to centrosomes. The completion of this work will address long-
standing questions about the role of mRNA localized to centrosomes within a genetically tractable model. This
work will contribute to our understanding of centrosome regulation, aspects of which are deregulated in cases
of microcephaly and cancer.

Public health relevance
Project Narrative Centrosomes are required for error-free mitosis and other cellular functions, and their deregulation drives developmental disorders, such as microcephaly and cancer. This proposal investigates novel paradigms of centrosome regulation by examining the functional consequences of mRNA localized to centrosomes.